Acquisition of a flash chromatography and HPLC preparative system

Project Summary/Abstract
The goal of the parent grant is to develop effective sialidase inhibitors. Sialidases (also called
neuraminidases) are glycosidases responsible for the removal of sialic acid (Sia) residues (desialylation)
from glycan portions of glycocojugates. By desialylation, sialidases are able to modulate the functionality
and stability of the Sia-containing molecules and are involved in both physiological and pathological
pathways. Previous and our recent study indicate that lysosomal Neu1 sialidase could relocate to the cell
surface of macrophages upon LPS stimulation, where it causes desialylation of TLR4 receptor, leading to
TLR4 activation and subsequent production of pro-inflammatory cytokines. Dysregulation of TLR4
activation by LPS is responsible for chronic and acute inflammatory disorders that often causes dangerous
disease like sepsis that still lacks specific pharmacological treatment. Sialidase inhibitors are useful tools
for studying sialidase function and related mechanisms of the biological pathways. More importantly,
effective sialidase inhibitors can be used as drugs to regulate the pathological pathways caused by
sialidase, such as dysregulated TLR4 activation. Our recent study indicates that currently available pan
sialidase inhibitor and microbial sialidase inhibitors could not inhibit mammalian sialidase effectively.
Several mammalian sialidase inhibitors have been reported. However, current sialidase inhibitor design
has usually focused on active-site binding, neglecting the subcellular localization of the active enzyme,
therefore, they are less effective in vivo or may be even toxic as they will affect other sialidases inside of
the cells. Therefore, the objective of this application is to develop location-specific inhibitor for Neu1
sialidase and define the Neu1 sialidase’s involvement in LPS/TLR4 signaling pathway, which will be
accomplished by three specific aims: (1) Profile Neu1 sialidase expression and cell surface relocation in
macrophages upon LPS stimulation; (2) Develop lysosome-targeting Neu1 sialidase inhibitors for effective
regulating desialylation in LPS/TLR4 signaling pathway; (3) Develop cell surface-targeting Neu1 sialidase
inhibitors for effective regulating desialylation in LPS/TLR4 signaling pathway. This study is innovative
because it uses a novel approach that overcomes the current limitations in (a) profiling sialidase expression
and relocation and (b) inhibiting sialidase at subcellular location. The proposed project is significant
because it will (i) uncover specific desialylation that is critical to the LPS/TLR4 signal pathway and (ii)
develop novel sialidase inhibitors for effective regulation of desialylation in LPS/TLR4 signaling pathway.
Finally, this proposal will enhance the infrastructure of research and education at Cleveland State
University, allowing undergraduate students to learn a broad spectrum of experimental techniques, data
analysis and presentation skills used in modern scientific investigations.

Public health relevance
Project Narrative Dysregulated Toll-like receptors (TLRs) activation is responsible for chronic and acute inflammatory disorders that often cause most dangerous disease like sepsis. Sialidase-catalyzed desialylation is involved in TLRs activation, however, the detailed mechanism is still unclear. The proposed research aims to investigate the sialidase-catalyzed desialylation mechanism related to TLRs activation and develop novel sialidase inhibitors to manipulate dysregulated TLRs activation and thus to discover novel therapeutic approach.